A Phase 1-2 clinical program for the teatment of Microsatellite Stable Colorectal Cancer with the combination of SR-8541A, Botensilimab, and Balstilimab

ABSTRACT
Metastatic microsatellite stable colorectal cancer (MSS-CRC) accounts for 80% of CRCs with a standard of care
that provides a dismal 10% objective response rate (ORR). It is a cancer where immune checkpoint inhibitors
(ICIs) work poorly, innate immunity is known to be shut off, and ENPP1 levels are high. Recently, Agenus
reported in a Phase 2 study (NCT03860272) of their second-generation, Fc-enhanced CTLA-4 (Botensilimab)
and PD-1 (Balstilimab) inhibitors to have clinical activity and durable responses in heavily pretreated patients
with metastatic MSS CRC. The study also reported a manageable safety profile with excellent disease control
in patients with no active metastatic disease in the liver. Around 70% of patients had stable disease, with a 17-
19% ORR. While these results are an encouraging improvement from the standard of care, many of these
patients remain immune-resistant. In recent years, much emphasis has been placed on improving adaptive
immune responses to suppress tumor evasion. We propose ENPP1 as a novel dual immunosuppressive
checkpoint target that can directly modulate innate and adaptive immune responses through 2′3′-cGAMP and
adenosine levels within the tumor microenvironment (TME). To this end, Stingray Therapeutics has used the
Direct to Phase II SBIR award (R44 CA278144) and investor funding to advance our ENPP1 inhibitor SR-8541A
to human trials. Multiple selectivity studies, cancer cell line panels, normal cells, tolerability in the mouse, rat,
and dog, and toxicology in rat and dog show no direct cytotoxic activity or harmful effect. Combination studies of
SR-8541A and ICIs, including Botensilimab, showed robust tumor growth inhibition in the CT26 CRC model. Our
phase 1 dose escalation study (NCT06063681) to assess SR-8541A safety, tolerability, and pharmacokinetics
is ongoing, with no dose-limiting toxicities (DLTs) in the three dose cohorts tested to date. The current objective
for our ENPP1 program and the purpose of this Phase IIB Bridge SBIR application is to test the hypothesis that
adding an appropriate activator of the innate immune system, such as our ENPP1 inhibitor SR-8541A, will
enhance the breadth of response and durability when added to Agenus' adaptive immune modulators. In Aim 1,
we will conduct a phase 2 trial to evaluate the safety and efficacy of SR-8541A administered orally with Agenus
Botensilimab and Balstilimab for patients with MSS CRC. We received IND clearance for this study (#170805)
on July 26, 2024. In Aim 2, we will investigate the participants’ systemic immunity and that of the TME pre- and
post-treatment, as well as its association with clinical response as part of the exploratory objective of the phase
2 trial. If successful, SR-8541A could substantially modify the landscape of treatment options for patients with
MSS CRC and other solid tumors.

Public health relevance
PROJECT NARRATIVE Current immunotherapies activate only the adaptive immune system and prove ineffective when cancer silences the innate immune response, the other central arm of immunity. Stingray Therapeutics has developed SR-8541A, a novel potent small-molecule inhibitor of ENPP1 (ectonucleotide pyrophosphatase/phosphodiesterase family member 1), that works as a novel dual checkpoint regulator of the STING pathway that can directly modulate innate and adaptive immune responses through 2′3′-cGAMP and adenosine levels within the tumor microenvironment. We hypothesize that adding an appropriate activator of the innate immune system, such as our ENPP1 inhibitor SR-8541A, will generate a robust and durable clinical response rate when combined with immune checkpoint inhibitors for the treatment of immune-resistant tumors such as microsatellite stable colorectal cancer.